Establishing therapeutic efficacy and uncovering mechanisms of tumor suppression

Project Summary/Abstract My research is focused on elucidating the cellular and molecular mechanisms that constrain malignant cancers. It is known that cells possess intrinsic and extrinsic tumor- suppressor mechanisms that are orchestrated by a handful of key tumor-suppressor genes. However, the inability to restore tumor suppressor function at will in established tumors has hampered our understanding of their functions. The project proposed within this K99/R00 award outlines the creation and implementation of novel mouse models that allow gene inactivation and gene restoration to be controlled in a tissue-specific and temporal manner. The research proposed within this application has been shaped by my experiences studying the consequences of telomere dysfunction in a model of Burkitt's lymphoma and by my recent efforts to elucidate the in vivo effects of restoring the p53 tumor-suppressor gene in several models of diverse human cancers. These research projects solidified my interests in pursuing a career studying the fundamental components of human cancer progression. My desire to interrogate the biology of tumor-suppression requires the development of novel genetic systems in which tumor-suppressor gene function can be inactivated and then subsequently restored. The systems that we propose herein utilize autochthonous mouse models and genetically defined human cancer cells. Comparative analysis of these systems will enhance discovery of fundamental mechanisms of tumor suppression by capitalizing on the relevant in vivo setting and the relevant organism in which to study human cancer. The facilities at the Koch Institute at MIT, and the expertise that my mentor, Dr. Jacks, can provide will be invaluable for successful implementation of this project. The goals of these experiments outlined within are: ? to highlight the therapeutic potential of targeting these tumor-suppressor pathways as a means to eradicate cancer, ? to identify relevant mechanisms by which tumor-suppressor genes inhibit cancer formation or progression in a variety of tumor types, ? to uncover biological programs unleashed upon tumor-suppressor gene restoration, and ? to identify specific novel targets for therapeutic intervention. The research environment in the Jacks Laboratory, MIT, and the surrounding area offers unmatched opportunities for scientific discussion, collaboration, and training. Currently, I supervise an undergraduate student and a technical assistant that work directly with me on experiments pertaining to my research. This is an incredible experience that will endow me with many of the necessary skills to manage an independent laboratory. The scientific community at MIT, the Broad Institute, and Harvard Medical School offers countless seminars and workshops that will continue to foster my scientific development. My immediate goals are to develop the research platform described in this application and to demonstrate its potential to unlock heretofore uncharacterized molecular and cellular mechanisms of tumor suppression. It is my intention to start an independent research program that will capitalize on these in vivo systems by studying multiple tumor-suppressor genes in a variety of important tumor types. For the long-term, I am confident that these experiments will provide a foundation on which my research program can grow. I look forward to educating and recruiting students and postdocs that share my passion for cancer research.

Public health relevance
Project Narrative Relatively few key tumor-suppressor pathways are mutated in a variety of human cancers. Unfortunately, we have very little understanding of the relevant tumor-suppressor programs that these genes control in each tumor type. Further, tools to interrogate these functions in vivo are lacking. My goals are to develop mouse and human cell models to interrogate tumor-suppressor gene function in established cancers, and study tumor regression programs in the hopes to better understand tumor biology and identify novel therapeutic targets. __SpecificAimsTextDelimiter__ 10-SPECIFIC AIMS: Our objectives are to ascertain the therapeutic efficacy of tumor-suppressor gene restoration in prevalent human tumor types and to uncover the biological mechanisms that mediate tumor suppression. Toward these ends, we propose experiments using autochthonous cancer models and transformed human cells to interrogate the effects of restoring tumor-suppressor gene function in established tumors. The data gleaned from these analogous experimental systems will synergize to focus our attention toward contextually relevant gene expression and biochemical programs of tumor suppression and regression. These studies will greatly enhance our understanding of cancer biology by establishing the therapeutic efficacy of activating tumor-suppressor gene networks, and highlighting specific biochemical pathways that facilitate tumor regression. The Specific Aims Are: Specific Aim 1: Create and validate tumor suppressor on-off-on alleles We will generate mice harboring novel 'on-off-on' alleles that allow normal gene function to be inducibly inactivated and then subsequently reactivated in a temporally controlled manner. We will generate murine embryonic fibroblast (MEF) cell lines from these mice and will employ standard cell culture and molecular assays to validate the expected cellular phenotypes and gene expression patterns after tumor-suppressor gene inactivation and restoration. Specific Aim 2: Determine the cellular and molecular effect of p53 and Rb tumor- suppressor gene restoration in prostate cancer We hypothesize that restoration of tumor-suppressor gene function in established cancers would activate latent anti-cancer mechanisms. We will use tissue-specific expression of a site-specific recombinase to initiate cancers in the prostate. Restoration of tumor-suppressor gene function in autochthonous tumors will uncover pathways whose inactivation is required for maintenance of specific tumor types, in a relevant environmental context. Further, these experiments will highlight the therapeutic potential of stimulating these pathways to treat human cancers. Specific Aim 3: Define cell intrinsic tumor-suppressor programs by comparative gene expression analysis in mouse and human derived cancer cell lines Gene expression analysis of cancer-cell-intrinsic programs will be obtained after tumor- suppressor gene restoration in cancer cell lines generated from mouse prostate tumors and from transformed prostate epithelial cells engineered to allow re-expression of p53 and Rb. Cross-reference of in vitro cell line and in vivo tumor gene expression analyses will allow definition of biological programs ongoing within cancer cells as well as in cells of the tumor micro-environment. ! !